A National Test of a Culturally Tailored mHealth Integrated Smoking Cessation and Mental Health Intervention for Black Adults with HIV

ABSTRACT
People with HIV/AIDS (PWH) are twice as likely to smoke cigarettes compared with the general population. Further,
PWH are less likely to quit smoking, likely due to barriers including co-occurring behavioral risk factors, stigma, limited
resources, experiences of racism and discrimination, and diminished access to health care. Importantly, cigarette
smoking is a significant risk factor for both HIV-related and non-HIV-related morbidity and mortality among PWH.
Health disparities observed among smokers with HIV are compounded by the tendency for PWH to have lower
incomes, lower education attainment, and lower access to healthcare. Suboptimal rates of smoking cessation and HIV
disease management among Black PWH who smoke appear to be related to increased exposure to interoceptive-
stress symptoms (e.g., anxiety, bodily sensations, stress-related burden due to racism or HIV diagnosis discrimination
or stigma). Consequently, smoking cessation interventions and HIV disease management directed toward Black
PWH who smoke might benefit from a specific focus on decreasing emotional reactivity to interoceptive stress.
Anxiety sensitivity (AS) is a candidate mechanism pertaining to the expectancy that interoceptive sensations are
personally dangerous, which escalates emotional reactivity. Yet, only one study has leveraged the potential of AS to
better understand smoking, HIV disease management outcomes, and interoceptive stress relations among Black
PWH who smoke. Our group, along with collaborating colleagues, has developed smoking cessation interventions for
PWH that engage AS to increase smoking cessation success. Early work included in person smoking cessation
interventions. Our more recent efforts have focused on developing and testing an integrated, culturally appropriate,
mHealth intervention for smoking cessation, AS reduction, and HIV disease management improvement for Black
PWH who smoke (MASP+). MASP+ targets multiple health conditions that interfere with successful aging: smoking,
mental health, and HIV disease management. To date, MASP+ has only been available to patients receiving HIV care
within a single, urban community clinic. This proposal aims to test MASP+ in a national sample of participants with
treated and untreated HIV. First, we propose to review already developed MASP+ materials with 30 members from
our priority population to ensure their appropriateness and therapeutic fit. Next, we will recruit and enroll 300 Black
PWH who smoke to participate in a randomized controlled trial (RCT). Participants will be randomly assigned to: (1)
MASP+; (2) the National Cancer Institute (NCI) QuitGuide smartphone app for standard mobile smoking cessation
treatment; or (3) an assessment only control. Participants will complete a baseline assessment, daily ecological
momentary assessments, and follow-up assessments at weeks 1, 2 (quit date for MASP+ and QuitGuide), 3, 4, 5, 6
(week 6 includes a qualitative interview for a subset of participants), 28, and 54 via our InsightTM app. All participants
will have the option to receive nicotine replacement therapy. If the efficacy of MASP+ is established, it would serve as
a low-burden and highly accessible treatment option for smoking cessation, improved mental health, and improved
HIV care adherence/engagement, which all serve to support successful aging and improved well-being.

Public health relevance
African American/Black (hereafter referred to as Black) adults with HIV/AIDS who smoke constitute a disparities group for poorer smoking cessation outcomes, mental health outcomes, and HIV disease outcomes. To help address this public health issue, our team developed a tailored, adapted, highly accessible, and integrated smartphone application that aims to increase smoking cessation, promote mental well-being, and improve HIV outcomes among Black adults with HIV/AIDS who smoke, which we now seek to test in a large-scale, nationwide trial.